Dynamic cerebrovascular morphology changes in acute ischemic stroke

SUMMARY
The goal of this proposal is to investigate the dynamic changes in cerebrovascular morphology after acute
ischemic stroke and reperfusion therapy and also use cerebrovascular morphological features to improve stroke
outcome predictions. Stroke is among the leading causes of death and disability worldwide. Acute Ischemic
stroke (AIS) constitutes approximately 90% of all strokes and is caused by a blockage or significant narrowing
of the brain vessels. The resultant disruption in the blood flow patterns downstream of the occlusion could place
the under-perfused regions of the brain at risk. Acute reperfusion therapies can restore the blood flow but vessel
recanalization and improve outcomes when performed early after AIS. A well-connected collateral supply
system, a redundant network of bypass vessels existing in the brain, is correlated with smaller final infarct size
and more favorable outcomes. However, a detailed evaluation of the collateral supply remains challenging due
to the small vessel size and network complexity. Timely diagnosis and treatment of AIS, as well as an accurate
prediction of response to reperfusion therapies, risk of major complications, and long-term outcomes, are pivotal
to patients, families, and providers to guide treatment pathways. However, accurate predictive models are
lacking despite efforts to use a large number of clinical and imaging biomarkers. Brain vascular morphology and
geometrical features have been shown to correlate with the development of cerebrovascular disorders. We
recently developed an automatic algorithm that can extract the brain’s vascular morphologic and geometric
features from the commonly used MR and CT angiograms in healthy subjects and AIS patients. We propose
developing further and validating this algorithm to automatically extract complex cerebrovascular morphology in
real-time. We also propose developing predictor models to accurately use the cerebrovascular morphologic
features, collateral index, and other clinical and imaging information collected at admission to predict major
complications and long-term outcomes after AIS.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to develop a fully automatic algorithm to extract geometric features from brain vessels of stroke patients in real-time and the effects of ischemic stroke on vascular alterations. We will use these features to improve the prediction of major complications and long-term outcomes after stroke and acute reperfusion therapies.